Hyperglycemia in Turner syndrome: Mechanisms and X chromosome contributions

PROJECT SUMMARY/ABSTRACT
Turner syndrome (TS) is a common genetic disorder caused by X chromosome (Xchr) abnormalities. Women
with TS have a four-fold higher risk of developing diabetes mellitus (DM) than the general population, and DM
contributes significantly to mortality. Despite the prevalence of DM in TS, the underlying mechanism(s) and
specific Xchr contributions driving diabetes risk remain elusive. As such, there are no specific preventative
strategies or treatments for DM in TS. The objective of the proposed project is to unravel the genetic and
physiologic mechanism(s) that lead to hyperglycemia in TS, using glycemic phenotyping in the context of Xchr
gene dosage, Xchr parent-of-origin, and genomic and epigenetic techniques. My central hypotheses are that
TS-associated hyperglycemia is a consequence of altered Xchr gene dosage (e.g., by Xchr imprinting and/or
structural Xchr variation) and that this contributes to a TS-specific phenotype of progressive beta cell functional
impairments first detectable only in response to oral glucose but not mixed macronutrients. To test these
hypotheses, we propose the following aims: (1) Identify Xchr contributions to the TS hyperglycemia phenotype
and (2) Determine if beta cell function is impaired in response to mixed macronutrients in TS. We will perform
multivariable analysis of data from National Institute of Child Health and Human Development’s Data and
Specimen Hub, which includes frequently sampled oral glucose tolerance tests (fsOGTT) and Xchr parent-of-
origin for 84 individuals with TS to determine if an Xchr parent-of-origin effect exists with respect to categorical
glycemia. Additionally, we will enroll 30 individuals with TS to undergo long-read Xchr sequencing in conjunction
with RNA sequencing. This will allow identification of candidate imprinted Xchr genes. This project also includes
paired fsOGTT and mixed meal tolerance tests (MMTT) for 20 individuals with TS and 10 age-, sex-, and BMI-
matched controls to further elucidate TS-specific impairments in beta cell function. Completion of the proposed
project will add to understanding of Xchr contributions to the TS hyperglycemia phenotype and contribute toward
identification of drug targets and/or new disease managements strategies. The project is also a vehicle for me
to achieve my career goals and objectives by providing me with expertise in glycemic phenotyping, genomic
and epigenetic techniques, multivariable statistics, and multisite study design and execution. The proposed
integrated research, mentorship, and didactic training program combined with the collaborative research
environment at the University of Iowa and off-site collaboration with faculty at the University of Minnesota and
Indiana University will foster my long-term career goal of becoming an independent investigator leading a
translational research program focused on isolating genomic and epigenetic contributions to diabetes risk.

Public health relevance
PROJECT NARRATIVE Women with Turner syndrome (TS) have a much higher risk of developing diabetes compared to the general population; however, the reasons for this are unknown. Because women with TS have alterations in their X chromosomes, much of the proposed work will focus on the role of the X chromosome in diabetes development. Knowledge gained from this project will help us better understand the cause(s) of diabetes in TS; because the role of the X chromosome in diabetes is understudied in the general population, this knowledge may be useful for our overall understanding of diabetes.